Mechanisms of gene regulation by an E3 ubiquitin ligase during neurodevelopment

Project Summary
During development, fixed genetic programs generate the neuronal diversity required for the complex circuits
that generate and modulate behavior. Other developmental mechanisms work in tandem with these fixed
programs and regulate gene expression in response to neuronal activity and other extrinsic cues. How these
different developmental processes are controlled and coordinated during neurodevelopment remains a major
question. The nematode C. elegans is a powerful model for the study of neurodevelopment, as most C.
elegans neurons quickly assemble into circuits during embryogenesis. By using C. elegans we can (1) observe
neurodevelopment in real time, (2) deploy powerful genetic and genomic tools, and (3) observe the
consequences of genetic manipulations on nervous system structure and function. This project will focus on
the development of a pair of C. elegans chemosensory neurons, the BAGs, which control behavioral
responses to aversive cues in the environment. Prior studies revealed an unexpected role for the p38 MAP
kinase PMK-3 during a critical period in embryonic development when BAG neurons establish expression of
genes required for their function. Neural activity during this critical period also influences BAG neuron
development. To determine how PMK-3 regulates gene expression during neurodevelopment, we performed a
genetic screen for modifiers of the gene expression and functional defects caused by mutation of PMK-3.
Through fine mapping a suppressor mutation, I identified the highly conserved E3 ubiquitin ligase HECD-1 as a
factor that acts either downstream of or in parallel to p38 MAPK. The proposed research plan will determine
the mechanism by which HECD-1 regulates gene expression during nervous system development. Because
mutation of the human homolog of HECD-1 has recently been linked to severe neurodevelopmental disorders,
these studies will advance understanding of molecular mechanisms that go awry in neurodevelopment to
cause disease.

Public health relevance
Project Narrative My studies of nervous system development in the model organism C. elegans have identified a role for a highly conserved ubiquitin ligase in a neurodevelopmental process that is instructed both by genetic programs and neural activity. The human homolog of this ubiquitin ligase has recently been linked to severe neurodevelopmental disorders. I will determine how this highly conserved enzyme functions with the goal of advancing understanding of fundamental mechanisms of nervous system development and how they mutate to cause neurodevelopmental disorders.